Systematic Vertebrate Functional Genomics

Abstract
With the generation of more than 100 sequenced vertebrate genomes, the current key question is how to
determine the role(s) of uncharacterized gene products in specific biological and pathological processes. For
example, genes associated with human disease are being discovered at a rapid rate, thanks in part to the
development of next generation sequencing technologies. However, the biological functions underlying this
linkage are often unclear, in part because the majority of published work investigates genes encoded by ~10%
of the genome. The overall purpose of this long-standing and collaborative research program is to
develop innovative ways to address this key gap of functional annotation in genome science. For
example, mitochondria have integral functions in metabolism, organ homeostasis, apoptosis and aging. They
also play important but still largely perplexing roles in human pathophysiology, as demonstrated by the
enormous biological variation and diverse disorders in patients with mitochondrial disease that can
compromise nearly every organ system. Over 1100 known nuclear proteins reside in vertebrate mitochondria,
with the majority of unknown biological function or no known role in pathogenesis.
Deploying loss of function approaches in model systems has been essential to the annotation of the
genome to date from the discovery of novel processes to the biological mechanisms underlying disease.
Among vertebrates, Danio rerio (zebrafish) has emerged as an outstanding and pioneering vertebrate
amenable to both forward and reverse genetic approaches. This funding period will deploy at scale recently
developed genome engineering technologies designed to address these gaps in the field. We will use
Predominant Microhomology-mediated end-joining Allele (PreMA) generation for rapid functional screening
using reproducible allele generation in F0 animals. For those loci with accessible phenotypes, second phase
analyses will follow via GeneWeld large-insert targeted knock-in technology in conjunction with gene-breaking
protein traps for detailed functional annotation of the genome using targeted protein trapping in F1+ stable
lines. Mitochondria are the products of two genomes – the nucleus and from mtDNA. The conservation
between zebrafish and human in the mitochondrial genomes includes nearly identical size and perfect synteny
of all 37 protein-coding and RNA genes. We will also deploy our recently developed zebrafish mitochondrial
base editor to make the first majority heteroplasmy animal models with targeted mutations in mtDNA-encoded
proteins for in vivo functional annotation. We will use this pioneering model organism for mitochondrial
genomic annotation focusing initially on the mitochondrially encoded proteome and at a targeted panel
of vertebrate-specific, nuclearly encoded conserved mitochondrial proteins of unknown function. We
will annotate the functional role of these genes using a rich array of biological, phenotypic and biochemical
tests in this highly collaborative research program. This work will yield 1) Novel tools for rapid PreMA
deployment and new methods for targeted integration of Gene-breaking Protein Trap alleles will be generated
and disseminated 2) New biological and genomic annotation of vertebrate mitochondrial innovations in
development and regeneration including mechanisms underlying genetic compensation 3) Longitudinal
knowledge of mtDNA SNP heteroplasmy maintenance and 4) Complete a unique functional annotation of the
mtDNA-encoded proteome. This combination of novel technologies, annotation and genome science will
establish important new functional information on the role of mitochondria in biology that, when compromised,
underlies disease.

Public health relevance
Narrative Despite the rapid progress in DNA sequencing, the overwhelming majority of our genome encodes proteins with little or no functional annotation such as the over 1000 proteins that make up the dynamic intracellular organelle, the mitochondria. We will use innovative genetic engineering methods to precisely mutate both mitochondrially encoded and vertebrate-specific nuclear-encoded mitochondrial genes for a rich array of biological, phenotypic and biochemical tests using the zebrafish in this highly collaborative and unique research program. This combination of novel technologies, annotation and genome science will establish scalable new genome science methods and generate important new functional information on the role of mitochondria in biology that, when compromised, underlies disease.